Novel Regulatory Mechanisms Underlying Inside-out Integrin Activation

Project Summary This is a request for an NIGMS Administrative Supplement to NIGMS grant R35GM119560, to purchase an ÄKTA Pure 25L chromatography system. The PI’s current chromatography system is heavily utilized, and this represents the rate-limiting step for further progress in this already-successful project. We currently rely on an older instrument that has been discontinued by the manufacturer and can no longer be supported for repairs as needed. This is a joint request with another NIGMS-funded investigator, Dr. John Karanicolas, whose research group has also exceeded their chromatography capabilities and who also relies on a nearly-identical older instrument. Access to the requested ÄKTA Pure 25L chromatography system will provide the necessary capabilities to maximize productivity and fully achieve the aims of both NIGMS-sponsored research projects. Institutional matching funds will contribute to the purchase of this instrument.

Public health relevance
Project Narrative Abnormal expression and hyperactivity of integrins lead to severe diseases including cardiovascular diseases, impaired inflammatory responses, and enhanced tumor metastases. We have achieved significant progress towards our proposed aims to elucidate the regulatory mechanisms underlying integrin activation. Since our studies require a large amount of protein purification experiments, we request funds to obtain the ÄKTA Pure 25L that will ensure our research capacity.